The role of the gut microbiota in sarcopenia

Summary
A key determinant of geriatric frailty is sarcopenia, the age-associated loss of skeletal muscle mass and
function. Recent estimates indicate that up to one-third of the elderly population may suffer from frailty. Frailty
often leads to loss of functional independence and is among the leading risk factors for falls in the elderly. In
fact, as life expectancy continues to increase, the maintenance of muscle strength is an important factor that
contributes to a higher quality of life. Although the etiology of sarcopenia remains to be determined, proposed
contributing factors include the loss of innervation and motor unit decline, oxidative stress, aberrant autophagy
and inflammation. There is emerging evidence for the existence of a gut-skeletal muscle axis. On the basis of
this connection, there has been much speculation that dysbiosis of the gut microbiota might have a role in the
development of sarcopenia. While plausible mechanisms have been proposed through which dysbiosis might
contribute to the development of sarcopenia, there remains a paucity of direct evidence to support such
mechanisms. The purpose of this exploratory grant is to test the hypothesis that dysbiosis of the gut microbiota
promotes sarcopenia by inducing a state of anabolic resistance in skeletal muscle through TLR4
hyperactivation of mTORC1 signaling. To test this hypothesis, the following aims will be pursued: Aim 1:
Determine if the gut microbiota from aged mice can induce sarcopenia in adult mice; Aim 2: Determine if the
gut microbiota from adult mice can rescue sarcopenia in old mice. If the results of the proposed experiments
provide evidence to support the hypothesis, a future R01 application will seek to rigorously test the proposed
mechanism by determining if a skeletal muscle-specific TLR4 knockout prevents sarcopenia despite low-grade
systemic inflammation induced by gut microbiota dysbiosis.

Public health relevance
Narrative A key factor contributing to becoming frail as a person gets older is the loss of skeletal muscle size and strength. Why people lose muscle as they get older is not known but one possibility is the bacteria in the gut become disturbed (dysbiosis). The purpose of the proposed research is to determine if gut dysbiosis causes the loss of skeletal muscle size and strength associated with aging.